Defining the epigenetic landscape and therapeutic vulnerabilities of Richter's syndrome in CRISPR-based mouse models

Project Summary/Abstract
Richter’s syndrome (RS) is a critical complication of up to 10% of chronic lymphocytic leukemia (CLL) patients,
which develops as an aggressive transformation into a diffuse large B cell histology, and is mostly refractory to
existing therapies. RS pathogenesis remains largely unknown and cellular and mouse models for molecular
studies are limited. To address this challenge, Dr. ten Hacken has developed novel human-genetics inspired
mouse models through CRISPR-Cas9 multiplexed B-cell editing, recapitulating CLL transformation into RS.
Already through her preliminary studies, Dr. ten Hacken demonstrated how selected mutational co-occurrences
facilitate disease transformation, and are associated to distinct transcriptional changes and therapeutic
vulnerabilities—work that is presently near completion. Dr. ten Hacken is now planning to introduce a new set of
mutations in genes involved in epigenetic programming of B cells, which were identified as putative RS drivers
in recent human genomic analyses. In Aim 1, Dr. ten Hacken will introduce epigenetic drivers in mice to assess
the impact of the selected alterations (and their combinations) on CLL transformation. As part of this Aim, Dr.
ten Hacken will also assess the transcriptional and genetic faithfulness of these models to human disease. In
Aim 2, Dr. ten Hacken will functionally characterize the modeled gene mutations, while dissecting changes in
the epigenetic landscape underlying transformation of CLL into RS. Epigenetic dependencies identified through
these studies will be cross-compared with human RS datasets and validated in human primary samples with
similar genetic make-ups. In Aim 3, Dr. ten Hacken will perform in vitro and in vivo preclinical testing of a panel
of agents (comprehensive of chemotherapy and novel targeted agents) in order to design mutation (or co-
mutation) specific treatment strategies. To carry out the proposed work, Dr. ten Hacken has enlisted
collaborators who are experts in computational biology, systems immunology, mouse pathology, molecular
pharmacology, biostatistics, functional genomics and epigenetics. Dr. ten Hacken has outlined a 3-year career
development plan that will allow her to foster her personal professional development (including leadership, grant
writing, negotiation and communication skills), and to gain additional scientific training in bioinformatics and
biostatistics. Dr. ten Hacken’s independent research program will be focused on translational research in
hematological malignancies, with the longer-term objective of undertaking clinical correlative research and
functional genomic analyses of other lymphoid and myeloid malignancies. Through her proposed work, Dr. ten
Hacken anticipates to contribute 2 high-impact manuscripts within the award term. She will present yearly at
international conferences, and will be ready for her first R01 submission towards the end of Year 2. The proposed
studies are expected to provide critical insight into the biology and natural history of Richter’s syndrome, and the
mouse models Dr. ten Hacken is developing will represent useful tools to dissect pathogenic mechanisms and
test novel treatment strategies for this largely incurable malignancy.

Public health relevance
Project Narrative Richter’s syndrome (RS) is a critical complication of chronic lymphocytic leukemia (CLL) patients, and a barrier to CLL management, with patients exhibiting refractoriness to most existing therapies and a median overall survival of ~12 months. The evolutionary trajectories and biological mechanisms leading to RS development from the antecedent CLL are largely unknown, because of the relative rarity of primary RS samples and the limited availability of genetically-engineered mouse models. The objective of these studies is to dissect pathogenic mechanisms of RS in human genetics-inspired mouse models, to identify disease-specific oncogenic circuitries and targetable vulnerabilities, and to test a panel of drugs pre-clinically to provide the basis for tailored therapeutic interventions.